Cancer Research Training and Education Coordination

CANCER RESEARCH EDUCATION TRAINING AND COORDINATION (CRTEC): PROJECT SUMMARY
The goal of the Cancer Research Training and Education Coordination (CRTEC) is to increase the pool of next-
generation cancer researchers and professionals and to develop and integrate cancer-focused training,
education, and professional development activities across all levels of learners. This is realized through
sustaining and growing the depth and breadth of the cancer research enterprise by recruiting promising junior
faculty members, student/postdoctoral trainees, and other medical professionals, and by providing them with
strong mentoring and training support. CRTEC is led by Kounosuke Watabe, PhD, Associate Director, and
Heidi Klepin, MD, MS, Assistant Director. Both have extensive experience in translational and clinical cancer
research training and education. Annually, CRTEC provides career development services to over 800
individuals, including high school and undergraduate students, pre- and postdoctoral trainees, faculty members,
and medical professionals. Over the project period, CRTEC designed tailored programs that have trained more
than 180 under-represented minorities (URMs), or 22% of all its trainees. CRTEC also helped establish two new
NCI-funded T32 training programs and one NCI-funded R25 entitled, “Training Program to Promote Diversity in
Cancer”. Through this R25 award, CRTEC built a community network with two Historically Black Colleges and
University institutions in the catchment area of Wake Forest Baptist Comprehensive Cancer Center (WFBCCC)
to recruit underrepresented trainees. Over 100 Cancer Center members participate in seven other NIH-funded
training programs. Since 2016, more than 90 pre- and post-doctoral trainees are now independent faculty
members at various institutions, 13 faculty members received career development awards, and 18 junior faculty
obtained R-type research funding as a result of rigorous training and mentoring activities. CRTEC is strongly
committed to supporting the career development of next-generation cancer researchers and has developed
multiple innovative approaches, including a Cancer Career Development Award, Clinical Trial Boot Camp,
Director's Cancer Research Award for Trainees, NIH F/K grant workshops, and travel awards for pre- and post-
doctoral fellows. In addition, CRTEC successfully advocated for salary support of Institutional training program
Directors and funding for high school summer internships. To further strengthen the WFBCCC training
infrastructure, CRTEC sets four Specific Aims for the next funding period: (1) provide a strong infrastructure to
train next-generation cancer researchers and professionals, and sustain an integrated system to support
assessment, and outcome tracking for all levels of trainees; (2) coordinate and assist in mentoring activities and
career development; (3) coordinate CRTEC activities with Research Programs, Community Outreach and
Engagement, Clinical Protocol Data Management, Disease-Oriented Teams, and Shared Resources and
integrate with other institutional training efforts; and (4) support career development for underrepresented and
women trainees, faculty, and other medical professionals.